Cholecystokinin - Role in postprandial gastric motility

DESCRIPTION (provided by applicant): Obesity is a major health problem in many countries, leading to serious comorbidities. The gut is the first point in the body at which the quantity and quality of ingested nutrients is monitored. Therefore, it is important to understand the mechanisms by which nutrients are sensed in the gut, the neural pathways activated, and how these may be altered by long term changes in diet leading to increased food intake and obesity. Ingestion of high fat diets and increased adiposity is associated with an inflammatory state and diet-induced obesity is associated with low chronic plasma level of lipopolysaccharide (LPS), a breakdown product of the cell wall of Gram-negative bacteria. This observation, together with recent evidence showing a change in the gut microbiota in obesity and following ingestion of high fat diets, suggests a role for LPS in the development or maintenance of obesity. Vagal afferents express TLR4 (15), but how LPS influences CCK-dependent activation of the vagal afferent pathway or expression of orexigenic and anorexigenic receptors has not been explored. The goal of the proposal is to determine the mechanism by which activation of the vagal afferent pathway by CCK and lipid is attenuated by long term ingestion of a high fat diet, leading to a reduction in short term satiety, hyperphagia and altered body weight regulation. The hypothesis to be tested is that long term ingestion of a high fat diet inhibits the CCK-induced changes in receptor and peptide expression in vagal afferent neurons, resulting in the persistence of an orexigenic phenotype and reduced satiety. The first specific aim will address the role of LPS and TLR4 in the reduced sensitivity of the vagal afferent pathway to CCK in high fat diet-induced obesity. Experiments will determine the effect of chronic ingestion of a high fat diet on intestinal function that lead to an increase in plasma levels of LPS and on change in the phenotype of vagal afferent neurons and whether chronic administration of LPS recapitulates the diet-induced obese phenotype and attenuates CCK-induced changes in vagal afferent function. The role of TLR4 in reduced sensitivity of the vagal afferent pathway to CCK to HF diets will be determined using TLR4 null mice. The second specific aim will address changes at the level of the vagal afferent neurons to determine the mechanism by which a high fat diet inhibits the CCK- or feeding-induced change switch from an orexigenic to an anorexigenic phenotype in vagal afferent neurons. Experiments will determine that the switch from orexigenic to anorexigenic phenotype induced by CCK or feeding in vagal afferent neurons is abolished or attenuated in HF diet-induced obesity and that this occurs either leptin resistance or an upregulation of the ghrelin receptor in vagal afferent neurons, or a decrease production of intestinal apolipoprotein A-IV. The significance of this proposal is that a greater understanding of the plasticity of the vagal afferent pathway, together with the possibility of targeting a luminal site of action of an obesity treatment, will provide better targets for the treatment of obesity and other disorders that involve the sensory innervation of the gut, such as functional bowel disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Obesity is a major health concern in many countries and associated with serious comorbidities. This proposal will address the role of inflammatory processes in alteration of the gut-brain pathway that under normal conditions mounts appropriate changes in GI function and food intake but is dysregulated by ingestion of high fat Western diets. A greater understanding of the plasticity of the vagal afferent pathway, together with the possibility of targeting a luminal site of action of an obesity treatment, will provide better targets for the treatment of obesity and other disorders that involve the sensory innervation of the gut, such as functional bowel disease. Project narrative Obesity is a major health concern in many countries and associated with serious comorbidities. This proposal will address the role of inflammatory processes in alteration of the gut-brain pathway that under normal conditions mounts appropriate changes in GI function and food intake but is dysregulated by ingestion of high fat Western diets. A greater understanding of the plasticity of the vagal afferent pathway, together with the possibility of targeting a luminal site of action of an obesity treatment, will provide better targets for the treatment of obesity and other disorders that involve the sensory innervation of the gut, such as functional bowel disease. __SpecificAimsTextDelimiter__ Specific Aims Obesity is a major health problem in many countries, leading to serious comorbidities. The complex, hierarchical control of food intake and body weight involves the central nervous system that integrates information from several different sources, including the peripheral nervous system and humoral signals from the gut, liver, peripheral tissues and adipocytes. The gut is able to sense the quality and quantity of ingested nutrients and to mount appropriate physiological responses. Cholecystokinin (CCK), released by dietary protein and lipid, stimulates firing in vagal afferent neurons to induce intestinal feedback inhibition of GI function and food intake. Recent evidence has shown that CCK also regulates expression of receptors and neurotransmitters in vagal afferent neurons that play a role in regulation of food intake and GI function. Long term ingestion of a high fat diet is associated with decreased activation of the vagal afferent pathway in response to CCK and lipid; the mechanism is unclear but likely involves an alteration in the expression of receptors for orexigenic and anorexigenic peptides. Ingestion of high fat diets and increased adiposity is associated with an inflammatory state. In mice, diet- induced obesity is associated with low chronic increased plasma levels of lipopolysaccharide (LPS), a breakdown product of the outer membrane of Gram-negative bacteria. Moreover, chronic injection of low doses of LPS in mice induces obesity in the absence of a change in diet and mice null for toll-like receptor 4 (TLR4), the receptor for LPS, are resistant to the obesigenic effects of a high fat diet. This observation, together with recent evidence showing changes in the gut microbiota in obesity and following ingestion of high fat diets, suggests a role for LPS in the development or maintenance of obesity. Vagal afferents express TLR4, but how LPS influences CCK-dependent activation of the vagal afferent pathway or expression of orexigenic and anorexigenic receptors has not been explored. The goal of the proposal is to determine the role for LPS and TLR4 in the reduced activation of the vagal afferent pathway by CCK and lipid induced by long term ingestion of a high fat diet, leading to a reduction in short term satiety, hyperphagia and aberrant body weight regulation. We will test the hypothesis that long term ingestion of a high fat diet inhibits the CCK-induced changes in receptor and peptide expression in vagal afferent neurons, resulting in the persistence of an orexigenic phenotype and reduced satiety. In the first part of the proposal, we will determine the role of LPS and TLR4 in the reduced sensitivity of the vagal afferent pathway to CCK in high fat diet-induced obesity and show that: 1. chronic ingestion of a high fat diet is associated with a decrease in detoxification of LPS, an increase in intestinal inflammation and permeability, leading to increased levels of plasma LPS; 2. chronic administration of LPS recapitulates the diet-induced obese phenotype and attenuates CCK-induced changes in vagal afferent function; and 3. loss of TLR4 prevents the attenuation of CCK-induced activation of the vagal afferent pathway. In the second part of the proposal, we will determine the mechanism by which a high fat diet inhibits the CCK- or feeding-induced switch from an orexigenic to an anorexigenic phenotype in vagal afferent neurons. Experiments will determine that the switch from orexigenic to anorexigenic phenotype induced by CCK or feeding in vagal afferent neurons is abolished or attenuated in HF diet-induced obesity and is mediated by either: 1. leptin resistance in vagal afferent neurons; 2. upregulation of the ghrelin receptor in vagal afferent neurons or 3. decrease production of intestinal apolipoprotein A-IV. The gut is the initial interface in the body at which the quantity and quality of ingested nutrients is monitored. Therefore, it is critical to understand the mechanisms by which nutrients are sensed in the gut, the neural pathways activated, and how these may be altered by long term changes in diet leading to increased food intake and obesity. This proposal will take the novel approach of determining the role of the phenotype of vagal afferent neurons in the onset of obesity in response to a high fat, high calorie diet and the role of products of the gut microbiota in determination of the neurochemical phenotype. The impact of this proposal is that a greater understanding of the plasticity of the vagal afferent pathway, together with the possibility of targeting a luminal site of action of an obesity treatment, will provide better targets for the treatment of obesity and other disorders that involve the sensory innervation of the gut, such as functional bowel disease.